Examination and Refinement of a Novel Treatment for Posttraumatic Stress Disorder: Processing of Positive Memories Technique (PPMT)

7. Project Summary/Abstract
Posttraumatic stress disorder (PTSD) has devastating health consequences. Experiments link PTSD with
encoding/retrieval difficulties across memory types, and clinical studies have demonstrated beneficial impacts of
processing positive memories on well-being. Despite such evidence, current PTSD interventions primarily target
trauma memories; they also have significant dropout rates (19%-68%) and result in remission of PTSD for only
~50% of individuals. Augmentations have been proposed, however, they demonstrate modest incremental
effectiveness. Addressing these limitations, the proposed study aims to examine effects of and targets underlying
a novel PTSD technique focused on positive memories (Processing of Positive Memories Technique; PPMT)
drawing from experimental and memory-focused/positive psychology intervention research. By reliving and
emotionally engaging with salient positive memories, individuals may access and solidify positive values, affect,
strengths, and cognitions. Hereby, PPMT may engage mechanistic targets to reduce PTSD symptoms including
improvements in affect and in abilities to retrieve specific positive memories. Specific aims include (1)
examining PPMT’s effects; (2) examining mechanistic targets underlying PPMT’s effects; and (3) refining
PPMT. Methodologically, 70 individuals with PTSD will be randomly assigned to PPMT vs. Supportive
Counseling (SC) arms. For Aim 1, PPMT vs. SC arms will be compared on PTSD severity (primary outcome
variable; H1) and stress systems’ dysregulation (i.e., awakening salivary alpha amylase [sAA] and cortisol;
Exploratory H1). It is hypothesized that the PPMT arm will report greater decreases in PTSD severity and
sAA/cortisol ratios. For Aim 2, mechanistic targets underlying PPMT’s effects will be examined. It is hypothesized
that PPMT-related improved affect will mediate the association between study arm (PPMT vs. SC) and changes
in PTSD severity (H2). Data for H1 and Exploratory H1 will be analyzed using mixed-effects models; data for H2
will be analyzed using within-subjects cross-lag longitudinal mediation analyses. For Aim 3,
quantitative/qualitative data (Feedback Surveys) will be obtained from study participants/therapists on PPMT’s
feasibility (acceptability, screening, recruitment, retention, treatment adherence/fidelity), format, and content to
refine PPMT; data will be analyzed using frequency and mean estimates, and a deductive (question domains)
and an inductive (identification of themes) approach. Consistent with NIMH’s experimental therapeutics
approach, results may highlight potential mechanisms underlying PPMT’s effects and if deficits in positive
memory processes are mechanisms underlying PTSD. The proposed study will provide critical preliminary
evidence on the potential significance of targeting positive memories in PTSD interventions; and opportunities
to mentor students in intervention development research, PTSD assessment/intervention, and scholarly
activities.

Public health relevance
8. Project Narrative Efficacious evidence-based posttraumatic stress disorder (PTSD) interventions address the substantial burden of PTSD on the health of individuals and societies; however, these interventions have significant dropout rates and result in PTSD remission for only ~50% of individuals. To potentially improve PTSD intervention outcomes, the proposed R15 grant aims to examine effects of and targets underlying a novel PTSD intervention focused on positive memories (Processing of Positive Memories Technique; PPMT) among individuals with PTSD; PPMT’s effects on affect are hypothesized to aid reduction in PTSD severity. This significant and innovative study will provide (1) critical preliminary evidence regarding the role and significance of capitalizing on positive memories in PTSD interventions (including evidence on potential mechanisms underlying PPMT’s effects); (2) evidence for deficits in positive memory processes as potential mechanisms underlying PTSD; (3) alternative avenues to potentially enhance symptom-related outcomes and treatment retention of PTSD interventions with downstream societal, psychological, and public health benefits; and (4) a rich mentored research experience for student researchers at the University of North Texas.